Biomolecular Mediators of Aerobic Exercise effects on Cognitive and Brain Health in Remitted Late-life Depression

Abstract
Late-life depression (LLD) is a leading risk factor for Alzheimer’s disease and related dementias
(ADRD) and this risk persists even after depression is successfully treated 1-3. The neurotoxic effects of LLD
that may elevate dementia risk include elevated prevalence of cerebral small vessel disease 4-6, hippocampal
atrophy6, aberrant neurocircuitry within and across major brain networks (i.e., default mode network, executive
control network)7. Current pharmacologic depression treatments do not target persistent cognitive impairments
or key neurobiological abnormalities found in those with remitted LLD (rLLD), making it imperative to leverage
non-pharmacologic approaches to prevent the clinical onset of dementia. Exercise is currently the most
promising approach for preventing dementia 8-10, yet its efficacy to attenuate cognitive and brain health decline
in those with rLLD, a group at high-risk for progression to dementia, has not been tested. Exercise training may
be an optimal yet untapped intervention for potentially reversing the neurobiological hallmarks of LLD that
exacerbate cognitive and functional decline in this high-risk group11. However, to better understand the value of
exercise to attenuate cognitive impairment in rLLD, we must identify biomolecular targets of exercise that
mediate its downstream systemic brain changes and cognitive benefits in those with rLLD. The goal of this
proposal is to identify biomolecular targets within plasma extracellular vesicles that may mediate cognitive
benefits of aerobic exercise in older adults with remitted late-life depression, by examining change in
neurotrophic and inflammatory protein cargoes of acellular blood biomarkers called extracellular vesicles, and
via transcriptomic profiling of plasma EVs.
The proposed study leverages blood data from an ongoing K23 trial of 6 months of aerobic exercise
training relative to a social engagement group targeting cognitive and brain health in adults aged 60+ years
with rLLD. The proposed study complements the parent K23 trial by using innovative methods to identify
biomolecular targets of aerobic exercise within plasma EVs, which can cross the blood-brain barrier to
influence changes in markers of brain health and cognition. The results of this biomarker ancillary study,
interpreted with the primary outcomes of the parent K23 trial, will enable a multi-level characterization
(molecular, brain systems, behavioral) of whether and how aerobic exercise may attenuate cognitive
impairment among those with rLLD, a group at high-risk for progression to dementia.

Public health relevance
Project Narrative The overarching aim of the proposed study is to identify biomolecular mediators encapsulated within plasma extracellular vesicles of aerobic exercise effects on cognitive and brain health in older adults with remitted late-life depression, a group at high-risk for progression to dementia.